Partnerships for Biomedical Research in Arkansas

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. For a service-learning program for minority students on issues pertaining to cancer health disparities. This could help to improve cancer incidence and survival in underrepresented communities.